Predicting Weight Regain Following Weight Loss Using Physiological Measures of Appetite and Energy Expenditure

PROJECT SUMMARY / ABSTRACT
The success of behavioral weight loss programs is undermined by weight regain. Controversy exists about how
much physiological adaptations to the weight reduced state contribute to weight regain. Further, little is known
about the relative contributions to relapse of increased metabolic efficiency and increased appetitive drive. Even if
metabolic efficiency increases with weight loss, this does not necessarily mean that successful dieters are hypo-
metabolic in their weight-reduced state. To address these scientiﬁc questions, we will recruit 100 individuals into a
weight loss program based on a modiﬁed version of the Diabetes Prevention Program. Qualiﬁed participants will be
assessed at baseline and reassessed if they attain a minimum 7% weight loss (called month 0) and undergo follow-
up assessments 4 and 12-months later.
Reassessment at month 4 will allow us to study the transition to maintenance as a dynamic process (i.e., change
from month 0 to 4), not just as a discrete change of state (from baseline to month 0). Changes in physiological
measures of metabolism and appetite during weight loss will be used to predict individual differences in weight
regain. Physiological outcome measures will include: 1) energy metabolism (e.g., resting and non-resting energy
expenditure, 2) neural indicators of appetitive drive (e.g., striatal activation to food cues and food tastes) and 3)
samples will be collected for studies of neuroendocrine responses to fasting and fed states (e.g., leptin, GLP-1). A
comprehensive biobank of blood, fecal, muscle and adipose tissue will also be collected for future discovery
studies. Our measures and expertise will provide new insight into the physiological determinants of weight regain
following weight loss that could help improve obesity treatments in the future.

Public health relevance
PROJECT NARRATIVE The success of behavioral weight loss programs is undermined by weight regain. Controversy exists about how much physiological adaptations to the weight reduced state contribute to weight regain. Further, little is known about the relative contributions to relapse of increased metabolic efficiency and increased appetitive drive. This study will examine changes in energy intake and energy expenditure, and underlying metabolic drivers of these parameters, during the cycle of weight loss and weight regain. The results will identify key factors responsible for weight regain, and will have major implications for future behavioral treatment of obesity.